Effects of expectation on gustatory cortical activity

DESCRIPTION (provided by applicant): The brain processes sensory stimuli differently depending on whether an animal is awake or anesthetized. In anesthetized animals no internal cognitive activity influences the brain, and so stimuli are passively received and coded solely for their physical properties. In awake subjects, on the other hand, responses to stimuli are heavily modulated by ongoing mental processes (i.e. attention, expectation). The same stimulus, for instance, is interpreted differently depending on what the animal expects: humans - and their brains - led to expect a mild taste, for instance, can be fooled into thinking that a bitter taste is milder than it actually is. The present proposal is designed to study the neural and systems underpinnings of such phenomena: in particular, the experiments outlined here will address the extent to which expectation influences background activity of the brain and responses to sensory stimuli. The intrinsic rewarding/aversive nature of gustatory stimuli and the importance of food selection for animal survival make taste an ideal sensory system for directly studying the effects of expectation at both the neural and behavioral level. The experiments proposed will be conducted in awake rats; ensembles of single neurons will be recorded with multiple electrodes implanted in connected areas known to be involved in taste and expectation (GC, orbitofrontal cortex [OFC], basolateral amygdala [BLA]). Two different aspects of expectation will be investigated: generic expectation of an unknown stimulus (a process somewhat analogous to attention) and specific expectation of a known stimulus. For the first, rats will be trained to collect tastes by pressing a lever in response to a tone. In this paradigm, the tone will not provide any information regarding the identity of the taste-it will simply trigger an attentional shift related to the expectation of an unknown stimulus. Expectation of a specific stimulus, on the other hand, will be addressed in another subset of experiments involving the use of two tones, each specifically associated with the availability of a different taste at a press of a lever. In these experiments, the auditory cues will provide information about the specific taste anticipated. Two behavioral tasks will be used to study different aspects of specific expectation: the first task, a go/no-go in which one tone cues the availability of a palatable taste (sucrose or NaCl) and the other a punishment (quinine) at a press of a lever, will reveal the effects of expectation of particular tastes having opposite affective value. The second task, a two tone, two levers task in which each tone is associated with a taste available at a specific lever, relies on tastes with similar palatability. This task will specifically address the effects of expectation for stimuli with similar affective value but different chemical identity. Spontaneous activity, responses to anticipatory cues, and responses to unexpected and expected tastes will be recorded in GC, OFC and BLA to parse the effects of generic and specific expectations on taste processing. Finally, intracranial cannulae will be implanted in OFC and BLA and the contribution of these two areas in modulating GC activity will be studied for the experimental conditions described above. Understanding the degree to which internal states, such as expectation, shape sensory responses is a central question in the field of sensory neuroscience. The comprehension of how the brain responds to the expectation of tastes will shed light on the complexities of food selection choices of all mammals - including humans - and will provide important information which could potentially be applied to the study of obesity and eating disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE: This proposal is designed to understand the neural underpinnings of expectation of incipient taste stimuli. Expectation plays an important role in the perception of food and in its evaluation (Deliza and MacFie 1996; Hurling and Shepherd 2003; Small 2008); as such, this subject has important implications on issues relevant to public health, such as food liking and selection choices. Additionally, understanding the neural basis of expectation is relevant for the study of the neural mechanisms of placebo (Nitschke et al. 2006a; Nitschke et al. 2006b; Sarinopoulos et al. 2006) - a growing field of interest in neuroscience (Petrovic et al. 2005; Ploghaus et al. 1999). PROJECT NARRATIVE This proposal is designed to understand the neural underpinnings of expectation of incipient taste stimuli. Expectation plays an important role in the perception of food and in its evaluation (Deliza and MacFie 1996; Hurling and Shepherd 2003; Small 2008); as such, this subject has important implications on issues relevant to public health, such as food liking and selection choices. Additionally, understanding the neural basis of expectation is relevant for the study of the neural mechanisms of placebo (Nitschke et al. 2006a; Nitschke et al. 2006b; Sarinopoulos et al. 2006) - a growing field of interest in neuroscience (Petrovic et al. 2005; Ploghaus et al. 1999). __SpecificAimsTextDelimiter__ SPECIFIC AIMS Electrophysiological recordings made from gustatory cortical neurons in anesthetized rodents have provided fundamental insights into the organization of taste responses. The role of the gustatory cortex (GC) in taste processing, however, remains largely mysterious. A careful review of recent data from wakeful animals suggests that GC, as other sensory areas, rather than simply coding for the physical properties of stimuli, may function to interpret sensory information in relation to external task requirements and internal states. This re- conceptualization of cortical function hypothesizes the involvement of "high-order" areas, which would be responsible for providing cognitive and contextual information and ultimately for modulating sensory cortical activity. The general aim of the current proposal is to test and enrich these hypotheses. GC responses will be studied in active rats under task conditions that manipulate internal states related to the expectation of gustatory stimuli. The role of "top-down" modulations from orbitofrontal cortex (OFC) and basolateral amygdala (BLA), two expectation-related areas connected with GC and also involved in taste processing, will be tested. A combination of behavioral training, multielectrode electrophysiology and pharmacological techniques will be used to validate this theoretical framework. Specific Aim #1: To understand how general expectation modulates gustatory processing. In its simplest form expectation can be described as the anticipation of an unknown stimulus within a specific sensory modality. To study how this general expectation affects gustatory cortical networks and taste responses, rats will be trained to perform a cued self-administration task. Following the presentation of a tone-cue, the animal will press a lever to self-administer a taste out of four possible; in this paradigm the cue triggers the general expectation of gustatory experience without providing any information on the specific identity of the taste. In the same sessions, tastes will also be administered unexpectedly to the animal by the experimenter during the "inter- trial" period. Simultaneous recordings of neural ensembles in GC, OFC and BLA during this and other related tasks, will be analyzed to test the following hypotheses: 1) general expectation modulates responses to gustatory stimuli; 2) expectation promotes anticipatory and associative tone responses in GC that relate to those seen in OFC and BLA; 3) expectation alters the functional connectivity between GC, OFC and BLA. Specific Aim #2: To understand how specific expectations influence cortical activity. Environmental cues, unlike those used in Aim 1, typically provide specific information as to the identity of the incipient stimulus. To study different aspects of specific expectations two behavioral paradigms will be used: a two-tone, one-lever go/no-go task (in which one tone signals the availability of sucrose and the other signals quinine) and a two- tone, two-lever discrimination task (in which each tone signals the availability of a particular palatable taste at its own lever). Each task will allow tests of distinct hypotheses: the go/no-go task will test whether GC neurons are influenced by the expectation of tastes with opposite affective value; the two-tone, two-lever discrimination task will address the extent to which expectation of a specific taste quality modulates GC activity regardless of differences in affective value. The influence of specific expectations on taste processing will be further tested using "catch" trials in which the specifically unexpected taste will be delivered after a misleading cue. GC, OFC and BLA responses to a particular taste during normally cued deliveries (tone A - taste A), un-cued deliveries and catch trials (tone B - taste A) will be compared. Altogether this aim will test the following hypotheses: 1) a subset of tone responsive GC neurons can develop cue specificity and respond to either one of the two tones; 2) GC tone responses reflecting expectations of stimulus quality or affective value are associated with activity in OFC or in BLA respectively; 3) responses to catch trials differ in predictable ways from those in properly cued ones. Specific Aim #3: To determine the causal role of OFC and BLA in driving expectation-related activity in GC. Besides unveiling the full extent of gustatory cortical networks modulation by different types of expectation, the previous aims will provide insights on how these modulations relate to activity in OFC and BLA. Recent evidence implicates OFC and BLA in the different aspects of specific expectation: BLA seems to processes expectation based on affective value, while OFC supports anticipation of taste quality. To determine the involvement of these two areas in modulating expectation, rats will be tested with a subset of the behavioral paradigms described in Aim 1 and 2 and gustatory cortical activity will be recorded before and after reversible inactivation of OFC or BLA. These experiments will address the following hypotheses: 1) OFC and BLA are necessary for the development of tone responses and expectation-induced modulations of taste processing; 2) inactivation of OFC alters GC activity related to the anticipation of taste quality, whereas inactivation of BLA influences GC responses for expectation of affective value.